Developmental Funds

The Developmental Funds component of the CCSG is a critical resource for the UCLA Jonsson Comprehensive Cancer Center, as it provides the only continuing source of support from the CCSG to recruit new faculty and provide funding for JCCC members use of the University of California, Davis Mouse Biology Program for transgenic mice. The final authority over distribution of Developmental Funds resides with the Director, in consultation with the Director's Council. The highest priority is assigned to bringing new faculty recruits to UCLA and the JCCC through a search process in which the Cancer Center is a full partner. During the past funding cycle, Developmental Funds were used for recruiting faculty members who are both outstanding and in line with our strategic goals. We plan to continue this focus for Developmental Funds in the future. The budgetary request for Developmental Funds to recruit and retain stellar faculty in this renewal represents no increase over the current level. As discussed in Section 6.1, we have sunset our ES/Transgenic Shared Resource and have developed a strategic relationship with the University of California, Davis Mouse Biology Program. In keeping with the new CCSG guidelines, we are requesting funding to subsidize our members use of the Davis facility. A cooperative agreement between the JCCC and the Mouse Biology Program (MBP) at UC Davis has been established to meet JCCC member needs for genetically engineered mice. This will be particularly advantageous to JCCC members, because it provides them access to technology not available at UCLA.

Public health relevance
Developmental Funds are key to the successful recruitment and retention of important faculty members and our ability to provide JCCC members a subsidy for their use of non-UCLA shared resources.